Elucidating the Biological Differences Between Distinct Fibrillar and Non-Fibrillar Alpha-Synuclein Inclusions in Human Stem-Cell Models

Summary
Alzheimer’s disease (AD) and AD related dementias (ADRD) are unpreventable, incurable and remain poorly
understood. Their hallmark pathology consists of misfolded proteins in characteristic “inclusions” within subsets
of neurons and glial cells of the brain. Misfolding of the membrane-­associated protein α-­synuclein (αS) is central
to ADRD. Inclusions rich in αS in cortical and dopaminergic (DA) neurons are the hallmark lesions of dementia
with Lewy bodies (DLB) and Parkinson disease with dementia (PDD). But αS inclusions are also found in >50%
of AD cases, correlating with cognitive decline and frequently colocalizing with tau pathology. αS pathology is
strikingly heterogeneous and poorly understood. Common αS pathology comprises vesicle-­rich “pale bodies”
(PBs), amyloid-­rich Lewy bodies (LBs), or combinations of these. PBs have indeed been discussed as
precursors of LBs, but what gives rise to PBs and how they may convert into LBs remains enigmatic. The
ultrastructural features of PBs and LBs parallel enormous interest in the field in both amyloid and vesicle-­
trafficking pathologies in PD. In experimental settings, the seeding of neurons with pre-­formed fibrils leads to LB-­
like amyloid aggregates. These aggregates can under certain conditions spread and self-­template in adjacent
cells. Different amyloid fiber conformers (“strains”) lead to different patterns of neurodegeneration, with differing
levels of phosphorylated αS and tau. Human genetic studies have repeatedly implicated perturbed vesicle
trafficking and (membrane) lipid homeostasis as a fundamental and unifying feature in disparate forms of ADRD.
We hypothesize that altered cellular, and especially lipid, microenvironments can trigger αS amyloid formation
and the development of different strains and pathologies. An increasing body of evidence, including work from
our groups, indeed suggests that αS toxicity and aggregation can be modulated by altering cellular fatty acid
(FA) saturation or sphingolipid (SL) composition through manipulation of glucocerebrosidase (GBA) and stearoyl-­
coA desaturase (SCD), respectively. We propose to dissect the influence of these pathways on PB and LB
formation and transition in the most disease-­relevant patient-­derived induced pluripotent stem cell (iPSC)
models. Importantly, we will employ patient brain-­derived “seed” as the most relevant trigger for neuronal αS
aggregation. The use of both patient-­specific cell types and misfolded protein conformers will allow us to capture
“in the dish” both sides of the toxic equation in neurodegeneration. We recognize the importance, but also the
limitations, of postmortem end-­stage pathology in delineating disease mechanisms, and propose to establish
cross-­correlation between in vitro assays, human induced pluripotent stem cell (iPSC) models and postmortem
brain tissue. We will focus on iPSCs derived from patients with familial and sporadic synucleinopathies that are
matched to postmortem brain, including cases with concomitant levels of AD (β-­amyloid and tau) pathology. Our
approaches not only promise to shed light on the formation and consequences of amyloid strains in ADRD, but
will also point at potential interventions centered around the transient interaction of αS with lipid membranes.

Public health relevance
Project Narrative Alzheimer’s disease and related dementias are common, devastating and incurable disorders. The protein alpha- synuclein commonly aggregates in these diseases. Here, in patient stem- cell models and brain tissue, we thoroughly investigate the mechanisms through which this protein aggregates with a view to developing new understanding and therapies.